Subject Recruitment and Sleep Study Core

The Sleep Study and Recruitment Core is designed to provide important services to all three projects in the Program Project. The services provided are the following: 1. Subject Recruitment: The Core will provide an infrastructure with well-trained staff, cognizant of all issues about protection of subjects engaged in human research, who will take primary responsibility for recruitment of all subjects in the three projects of the Program Project. Performance of Sleep Studies: The Core will standardize the performance of sleep studies at the University of Pennsylvania and the University of Iceland, and conduct sleep studies at the University of Pennsylvania for all three projects. 3. Performance of More Complex Sleep Studies: The Core will provide skilled technologists for more complex procedures such as performance of Pcrit. 4. Review of Data: The Core will provide timely review (for quality and medical alerts) and scoring of all records and generate reports to be transferred to the Biostatical and Data Management Core (Core E). 5. Quality Assurance: The Core will conduct continuous quality assurance efforts for sleep studies to maintain high levels of technical performance of tests at the University of Pennsylvania and University of Iceland as well as scoring occurring in the Sleep Study Core Laboratory.